Implications of sequential bloodmeals on arbovirus transmission by mosquitoes

Brackney & Armstrong
Abstract:
Aedes aegypti is the primary vector for a number of human pathogens, including dengue virus (DENV;
Flaviviridae, Flavivirus), Zika virus (ZIKV; Flaviviridae, Flavivirus), chikungunya virus (CHIKV; Togaviridae,
Alphavirus) and yellow fever virus (YFV; Flaviviridae, Flavivirus), all of which present a continued threat to
human health worldwide. Understanding the endemic and epidemic risk of these arthropod-borne (arbo-)
viruses is critical to the success of public health preparedness and intervention. One key entomological
parameter informing risk estimates is vector competence (how able a mosquito is to become infected and
transmit an arbovirus; VC). Quantifying the competency of local vector populations can help inform the risk that
any one pathogen poses to a given community. This is often quantified in the laboratory by exposing
populations of local mosquitoes to an infectious bloodmeal and harvesting tissues at set time-points post
infection. While informative, this approach often fails to consider the biology and behavior of the vector
mosquito. For example, it is known that wild Ae. aegypti mosquitoes will imbibe several bloodmeals over the
course of a traditional laboratory-based vector competence study (e.g. bloodmeal every two to three days). To
address these shortcomings, we recently began examining the effects that multiple blood feeding episodes
have on the competency of Ae. aegypti mosquitoes for ZIKV. Our preliminary findings reveal that providing a
second non-infectious bloodmeal to ZIKV infected Ae. aegypti mosquitoes enhances viral escape from the
midgut and significantly shortens the duration between mosquito acquisition of ZIKV to transmission. In this
application we will examine the effects that multiple bloodfeeding episodes have on arbovirus infection of and
transmission by vector mosquitoes. Specifically, we will be 1) testing this phenomenon in other virus-vector
pairings, 2) evaluating the role of the midgut basal lamina in mediating the double-feed phenotype and 3)
determining if similar processes are mediating the ability of arboviruses to infect ovarian tissue and be
transmitted vertically.

Public health relevance
Brackney & Armstrong Narrative. Arthropod-borne (arbo-) viruses poses a continued and significant public health threat despite vast expenditures towards their control. Understanding the transmission dynamics and how vector behavior influences these dynamics will be critical to developing novel control strategies required to reduce human disease risk. Therefore, we will be examining the effect that the biologically-relevant multiple bloodfeeding behavior has on arbovirus infection within vector mosquitoes.